Cytoskeletal stability in stereocilia maintenance

PROJECT SUMMARY
Hearing depends on stereocilia, which are protrusions on sensory cells in the inner ear that exist as
membrane-enclosed bundles of actin filaments. If stereocilia are malformed during development or improperly
maintained, then people have congenital deafness or progressive hearing loss. The composition of the
stereocilia actin core is well-known and consists of a highly stable bundle of parallel actin filaments which form
a stiff rod. The core dimensions dictate the length and width of stereocilia. The addition or loss of actin from the
distal end of the core drives growth during development and shortening that occurs during some forms of
progressive hearing loss. Our proposed experiments focus on elucidating how actin is regulated at the tips of
developing stereocilia. Similar regulatory mechanisms may repair stereocilia during aging or following noise
damage. Understanding these mechanisms is therefore expected to be essential for understanding many
forms of hearing loss. This proposal builds on work done during the previous granting period, where we
discovered differences in actin turnover at the tips of stereocilia in mechanotransducing rows. We now present
evidence of a novel population of short actin filaments that exist at stereocilia tips but are not part of the actin
core. Experiments in mouse models will document the key characteristics of these tip filaments, how they are
regulated at the tips of mechanotransducing and non-mechanotransducing stereocilia, and how they contribute
to stereocilia development and maintenance.

Public health relevance
PROJECT NARRATIVE Hearing depends on the formation and maintenance of functional stereocilia, which are highly structured protrusions on the surface of sensory cells in the inner ear. Stereocilia cores are formed by bundles of the cytoskeletal protein actin, which determine the shape and stability of stereocilia. We propose to investigate a newly-identified population of short actin filaments at stereocilia tips that likely contribute to stereocilia development and maintenance.